Understand & overcome resistance to PD-1

Summary, Project 2: Characterizing and overcoming failure to respond to PD-1 blockade therapy
Merkel cell carcinoma (MCC) is a rare but often deadly skin cancer caused by the Merkel cell polyomavirus
(MCPyV) in 80% of cases or by UV-induced mutations. MCPyV T-antigen oncoproteins are persistently
expressed in virus-positive MCC (VP-MCC), while high numbers of UV-induced neoantigens are detected in
virus-negative MCC (VN-MCC), meaning both MCC subsets harbor immunogenic epitopes. Based on our early
studies of the immune response in MCC, our Seattle team led multiple clinical trials of PD-1/PD-L1 blockade
therapy that changed the standard of care for this cancer. PD-1 blockade has yielded high response rates (~55%)
in MCC as compared with other solid tumors, and markedly improved outcomes compared to cytotoxic
chemotherapy, the only prior option for advanced MCC. While many patients derive durable benefit, roughly half
do not respond (primary resistance), and initial responders often develop acquired resistance.
In the current funding period, Project 2 contributed to 40 publications that were cited 1,317 times and led to
multiple changes in MCC management guidelines. Our Seattle team played leadership roles in trials of PD-1/PD-
L1 therapy resulting in all three FDA-approvals for MCC. Using NIH support, we developed immune tools to track
and study MCPyV-specific T cells. These reagents allowed us to reveal a strong association between the
frequency of MCPyV-specific CD8 T cells in blood and response to anti-PD-1, across two independent clinical
trial discovery cohorts. In Aim 1, we propose to further test and validate the number and cell surface
characteristics of circulating cancer-specific T cells as putative biomarkers of immunotherapy response. These
approaches could provide therapeutic guidance for patients who do not respond to immunotherapy and enable
more accurate assessment of the immunogenicity of clinical trial agents. Aim 2 focuses on augmentation of
adaptive immunity against MCC via clinical targeting of immune evasion (i.e., triple checkpoint blockade) or via
a cell cycle checkpoint (ATR inhibition) in advanced, PD-1 refractory disease. Aim 3 will build upon our previous
findings to identify potentially targetable innate immune mechanisms that correlate with poor outcomes in
patients receiving PD-1 therapy.
This Project will be greatly enabled by our recent P01-funded progress in identifying biomarkers and immune
evasion mechanisms. These exciting findings are now being translated into several relevant clinical trials funded
by sources beyond this proposal. These trials will provide valuable samples to reveal mechanisms of response
and evasion that have direct relevance to immunotherapy of more common immunogenic cancers. This proposal
will thus address the most pressing needs in our field: to understand mechanisms of immune evasion relevant
to resistance to PD-1 blockade, to develop clinically useful biomarkers predictive of response, and to identify
effective approaches to overcome resistance to available immune therapies.

Public health relevance
Narrative, Project 2: Characterizing and overcoming failure to respond to PD-1 blockade therapy Merkel cell carcinoma (MCC) is an aggressive skin cancer driven either by the Merkel cell polyomavirus or by UV- mutations, and about half of patients with advanced MCC persistently respond to PD-1 blockade. During the current Project 2 funding period, we identified a strong biomarker of response (the number of circulating cancer-specific T cells) and several therapeutically addressable immune evasion mechanisms that are now advancing to clinical trials linked to this P01. Project 2 will engage expert collaborators to analyze powerful sets of biospecimens derived from clinical trials to achieve its goals: 1) Identify clinically feasible biomarkers of PD-1 response in MCC and 2) identify and overcome innate and adaptive mechanisms that mediate resistance to PD-1 pathway blockade.